Multifunctional Biodegradable Zwitterionic Polymer-Drug Conjugates for Multidrug Co-Delivery

Project Summary
Critical technological challenges have significantly restricted the applicability of polymer-based drug delivery
systems (DDSs). Aliphatic polyesters, such as polylactide (PLA) and poly(3-hydroxybutyrate) (P3HB), are
biodegradable and biocompatible, but their hydrophobicity and lack of functionalities limit their biomedical
applications. Polyethylene glycol (PEG) has been broadly used in DDSs, but can cause undesired
immunogenicity. Zwitterionic polymers (ZPs) have emerged as promising alternatives of PEGs, but typical ZPs
are non-biodegradable and may possibly result in severe in vivo side effects. Combination therapy has great
clinical potentials; however, the lack of appropriate DDSs limits its applicability. Cyclic polymers have shown
novel biointerface properties, but in-depth studies are needed to gain insights into their in vitro and in vivo
behaviors. To address these challenges, we design multifunctional biodegradable zwitterionic polymer-drug
conjugates (ZPDCs; with both open-chain and cyclic structures) as novel PEG-free DDSs. It is hypothesized that
such ZPDCs can possess a broad range of favorable biomedically relevant properties for effective multidrug
co-delivery. To examine the hypothesis, we propose to systematically investigate ZPDCs with three specific
aims: 1) to synthesize multifunctional biodegradable multidrug-containing ZPDCs, 2) to understand their
structure-dependent interactions with biochemical environments & cells, and 3) to understand their
structure-dependent in vivo behaviors. We will synthesize a library of well-defined ZPDCs with PLA or
P3HB-based backbones that carry sulfobetaine-based zwitterions, paclitaxel and gemcitabine as multidrug as
combination therapy for pancreatic cancer, cyanine5.5 as imaging dye, and plectin-1 targeted peptide as
targeting ligand. These ZPDCs will be prepared through living ring-opening polymerization of
alkene/alkyne-functionalized cyclic esters, followed by alkyne-azide and thiol-ene dual Click functionalization.
Comprehensive analytical approaches will be employed to characterize the ZPDCs to verify their well-controlled
structures. To achieve insightful understanding on their structure-dependent biointerface properties, systematic
biochemical, cellular and in vivo studies of ZPDCs will be performed. Research activities will include
anti-biofouling analysis, drug release study, degradation assessment, cytotoxicity assay, evaluation of cellular
uptake efficiency and mechanisms, the determination of blood circulation time, the measurements of
pharmacokinetics and biodistribution, the examination of immune responses, and the evaluation of therapeutic
efficacy in vivo. Together, the proposed R01 studies will establish the synthetic method for ZPDCs, provide key
insights into their structure-dependent biointerface properties, and elucidate their design rules. These studies will
lay a solid foundation for the development of ZPDCs as a new, PEG-free platform technology. The in-depth
comparative studies of cyclic and open-chain ZPDCs will provide critical guideline on topological design of
polymeric biomaterials. The outcomes of this project potentially may also benefit patients with pancreatic cancer.

Public health relevance
Project Narrative The applicability of polymer-based drug delivery systems (DDSs) has been significantly restricted by critical technological challenges, such as the undesired immunogenicity of polyethylene glycol (PEG) broadly used in DDSs, the lack of PEG alternatives with optimal comprehensive properties, the scarcity of clinically valid DDSs for combination therapy, and the deficient understanding on topological effects of polymer scaffolds. To address these challenges, we aim to develop multifunctional biodegradable zwitterionic polymer-drug conjugates (ZPDCs) as novel PEG-free multidrug co-delivery systems with favorable biomedically relevant properties. A library of ZPDCs with different main-chain topology and other structural features will be prepared and their structure-dependent biointerface properties will be systematically investigated through biochemical, cellular and in vivo studies.